Pain in Hidradenitis Suppurativa: Phenotypes and Stakeholder Perspectives

PROJECT SUMMARY/ABSTRACT
Candidate: This K23 career development award will prepare Lauren Orenstein, MD MS to understand
pain mechanisms and trajectories in hidradenitis suppurativa (HS) in order to develop and evaluate
targeted interventions that reduce pain and improve quality of life (QoL) in serious skin diseases. Through
this K23, she will pursue three career development objectives: (1) develop expertise in the conduct
and statistical analysis of prospective studies, (2) obtain skills in mixed methods, and (3) gain practical
experience in stakeholder engaged research for intervention development and evaluation.
Mentoring and Environment: Dr. Orenstein has assembled an internationally renowned mentor
team with complementary expertise and an outstanding track record of mentoring junior investigators.
Her primary mentors are: Rachel Patzer, PhD MPH (expertise: prospective study design, statistical
techniques, outcome validation, health services research) and Dio Kavalieratos, PhD (expertise:
mixed methods, stakeholder-engaged research, design and evaluation of complex behavioral and
health systems interventions). Her co-mentors are: Suephy Chen, MD MS (patient-reported outcomes
in skin disease), Amit Garg, MD (HS epidemiology and outcome metrics) and Daniel Harper, PhD
(pain mechanisms and quantitative sensory testing). Consultants include: John Ingram, MA MSc DM
FRCP FAcadMedEd (pain measurement in HS), Kimberly Curseen, MD (palliative care), Anne-Marie
McKenzie-Brown, MD (pain management), and Dong Li MD, MD PhD (biostatistics). As an Assistant
Professor of Dermatology, Dr. Orenstein will have access to the Dermatology Center for Outcomes
Research and Safety unit and the resources and institutional capital of Emory School of Medicine.
Research: HS is a chronic inflammatory skin disease affecting ~0.4% of adults that causes recurrent, painful
scarring abscesses leading to poor QoL. Pain is rated by HS patients as their most important symptom, yet
little is known about its mechanisms, trajectory, best practices for measuring HS pain, or effective treatments.
Specific Aims: In a prospective cohort study, we will identify HS pain mechanisms, determine the influence of
pain mechanisms on pain interference with daily activities, establish HS pain trajectory patterns, and optimize
HS pain measurement for clinical trials. In a separate study, we will use a mixed methods design to understand
domains of suffering, unmet pain needs, and pain care preferences in HS patients and their care partners. We
will present these data to a stakeholder panel consisting of HS patients, community advocates, and clinical
experts who will use Intervention Mapping techniques to generate recommendations for designing and
evaluating complex intervention(s) that reduce pain in HS. The proposed research will provide Dr. Orenstein
with the preliminary data and training to apply for an R01 focused on HS pain mechanisms and an R21 and
subsequent R01 to develop, pilot, and evaluate complex interventions to mitigate pain and suffering in HS.

Public health relevance
PROJECT NARRATIVE Hidradenitis suppurativa (HS) is a common, chronic inflammatory skin disease that causes severe pain, leading to poor quality of life, chronic opioid use, and elevated suicide risk. This research and career development plan will address critical research gaps by identifying HS pain mechanisms and trajectories to enable personalized medicine, performing a pain management needs assessment, and using stakeholder-engaged research to begin the design of complex interventions to alleviate HS pain. The data generated by this proposal and associated training will enable Dr. Orenstein to become an independent researcher whose work supports the mission of NIAMS by designing, evaluating, and implementing interventions to reduce pain and improve quality of life in HS and other serious skin diseases.